Developing and validating EHR-integrated readmission risk prediction models for hospitalized patients with diabetes

PROJECT SUMMARY/ABSTRACT
Hospital readmission is an undesirable, costly outcome that may be preventable. Hospitalized
patients with diabetes are at higher risk of readmission within 30 days (30-d readmission) than
patients without diabetes, and >1 million readmissions occur among diabetes patients in the US
annually. Certain interventions can reduce readmission risk, but applying these interventions
widely is cost prohibitive. One approach for improving the efficiency of interventions that reduce
readmission risk is to target high-risk patients. We previously published a model, the Diabetes
Early Readmission Risk Indicator (DERRITM), that predicts the risk of all-cause 30-d readmission
of patients with diabetes. The DERRI, however, has modest predictive accuracy (C-statistic 0.63-
0.69), and requires manual data input. Recently, we demonstrated that adding variables to the
DERRI substantially improves predictive accuracy (DERRIplus, C-statistic 0.82). However, using
this larger model to predict readmission risk based on manual input of data would be too labor
intensive for clinical settings. Indeed, most readmission risk prediction models are limited by the
trade-off between accuracy and ease of use; lack of translation to a tool that integrates with
clinical workflow; modest accuracy; lack of validation; and dependence on data only available
after hospital discharge.
The objectives of the current proposal are: 1) To develop more accurate all-cause
unplanned 30-d readmission risk prediction models using electronic health record (EHR) data of
patients with diabetes (eDERRI); 2) To translate the models to an automated, EHR-based tool
that predicts % readmission risk of hospitalized patients; and 3) To prospectively validate the
eDERRI models and tool. The new eDERRI models will expand upon the variables in the
DERRIplus based on availability in EHR data (e.g., sociodemographics, encounter history,
medication use, laboratory results, comorbidities, and length of stay). To develop the models, we
will leverage data from the PaTH Clinical Data Research Network (CDRN), a multi-center, 40-plus
hospital member of the National Patient-Centered Clinical Research Network (PCORnet). We will
apply state-of-the-art deep-learning methods to develop optimal predictive models. This project
will analyze a large, multi-center cohort of nearly 340,000 discharges with cutting-edge
techniques to develop better models and translate them to an automated tool that predicts
readmission risk for individual patients with diabetes. The proposed tool would identify higher risk
patients more likely to benefit from intervention, thus improving care and reducing costs.

Public health relevance
PROJECT NARRATIVE This project seeks to develop more accurate models that predict the risk of repeat hospitalizations among patients with diabetes. The models will be programmed into a tool that will be integrated with an electronic health record system and automatically predict the re-hospitalization risk of patients. Such a tool could be used to identify higher risk diabetes patients more likely to benefit from intervention, thus improving care and reducing costs.